Targeting ER+ Breast Cancer Through Induced Viral Mimicry

PROJECT SUMMARY
Repetitive elements (REs) compose ~45% of the human genome and are normally transcriptionally silenced in
somatic cells, although the mechanism had remained elusive. Through a high-content RNAi screen, we identified
the largely uncharacterized protein FBXO44 as an essential repressor of REs in breast cancer cells. FBXO44
bound repressive histone H3 lysine 9 trimethylated (H3K9me3) nucleosomes at the replication fork and recruited
H3K9me3 methyltransferase SUV39H1, ubiquitin ligase CRL4RBBP4/7, and histone deacetylase and chromatin-
remodeling complex Mi-2/NuRD to transcriptionally silence REs post-DNA replication. FBXO44/SUV39H1
inhibition transcriptionally reactivated endogenous retroviruses (ERVs) and retrotransposons (e.g. Alu, LINE-1)
in breast cancer cells, leading to extensive DNA replication stress and stimulation of RIG-I/MDA5-MAVS and
cGAS-STING intracellular antiviral pathways to promote enhanced immunogenicity and decreased
tumorigenicity. In silico analysis revealed the FBXO44/SUV39H1 pathway inversely correlated with DNA
replication stress, antiviral pathways, and cytotoxic T and natural killer (NK) cell infiltration in human breast
tumors. Importantly, FBXO44/SUV39H1 were found dispensable for RE silencing in normal cells and their
inhibition had no effect on H3K9me3 levels, DNA replication stress, or viability, suggesting a therapeutic window.
Our hypothesis is that FBXO44/SUV39H1-mediated RE silencing is an epigenetic vulnerability of breast
cancer cells that could be targeted to inhibit tumor growth/progression and enhance the efficacy of
certain antitumor therapies through the unique mechanism of induced viral mimicry. In this proposal, we
will evaluate 3 potential therapeutic applications of FBXO44/SUV39H1 pathway targeting in the treatment of
estrogen receptor (ER)+ breast cancers based on our preliminary data: 1) prevention of bone metastasis relapse
through stimulation of NK cell recognition and killing of dormant breast cancer cells; 2) enhancement of immune
checkpoint blockade (ICB) therapy through stimulation of IFN signaling and intratumoral infiltration of cytotoxic
T cells; and 3) synergy with PARP inhibitors through induction of DNA replication stress and double-strand
breaks (DSBs) at REs. These studies could lead to the development of a safe and effective therapeutic approach
that selectively induces viral mimicry in ER+ breast cancer cells to prevent bone metastasis relapse and enhance
the efficacy of ICB and PARP inhibitor therapies, undoubtedly leading to a significant reduction in disease
mortality.

Public health relevance
PROJECT NARRATIVE The transcriptional reactivation of endogenous retroviruses and retrotransposons beyond a threshold level of tolerance in cancer cells stimulates intracellular viral defense pathways that can promote antitumor effects and augment the effectiveness of certain cancer therapies. This therapeutic approach, termed viral mimicry, could hold promise for the treatment of advanced estrogen receptor (ER)+ breast tumors that often develop resistance to hormone-based therapies and recur years or even decades post-diagnosis. Understanding how SUV39H1 targeting induces viral mimicry selectively in ER+ breast cancer cells could lead to a safe and effective therapeutic approach to prevent metastatic recurrences and extend the utility of immune checkpoint blockade (ICB) and PARP inhibitor therapies to this tumor subtype, undoubtedly leading to a significant reduction in disease mortality.